Vision Science Training Program

ABSTRACT
The vision scientist of tomorrow must appreciate fundamental biological processes and the challenges of
ophthalmologists/optometrists to effectively utilize modern tools of research in the pursuit of new knowledge
about diseases of the eye that ultimately lead to the development of adjunct and novel therapeutic
interventions. To facilitate the distribution of knowledge in the field of vision science, the Vision Science
Training Program goals are to continue to provide fundamental and research training to 2 pre-doctoral and 1
postdoctoral fellows. The program is unique in that it includes 21 vision research faculty from two independent
institutions including the University of Oklahoma Health Sciences Center (OUHSC) and the Oklahoma Medical
Research Foundation (OMRF). The participating training faculty are particularly strong in the four
subdisciplines emphasized in the Vision Science Training Program, which include 1) Ocular Immunology and
Infection, 2) Visual Signal Transduction, 3) Cellular Stress and Structure, and 4) Vision Neuroscience and
Genetics. The four subdisciplines have been revised based on the addition of new faculty and areas of vision
research. These faculty preceptors have interacted with one another and with trainees at OUHSC/OMRF for
several years, forming a network that is well-suited to train a cohesive group of pre- and postdoctoral fellows in
visual sciences. The program includes students and fellows from national and international sources, has strong
NIH-funded research programs, and has ample core facilities, all of which foster an atmosphere of excellence
in training. The pre-doctoral students are eligible for the training program after completion of their lab rotations
and qualifying exam in their home departments. The Vision Science Training Program will provide in-depth
enrichment in the 4 subdisciplines to the pre- and postdoctoral trainees through a number of courses, some of
which focus specifically on vision, and professional development and networking opportunities. Postdoctoral
fellows are strongly encouraged to take coursework and to mentor pre-doctoral students to enhance their
training experience. The Visual Science Training Program Advisory Committees select the pre- and
postdoctoral trainees and act in an advisory capacity. The yearly interactive Vision Science workshop, the
Vision Science Journal Club, and courses related to vision science have been effective in bringing pre- and
postdoctoral fellows together with training faculty in an environment that fosters excellence. The first five years
funded 10 pre-doctoral and 5 postdoctoral trainees. During this time, our program trained 14 pre-doctoral and 6
postdoctoral trainees, most of whom have taken the next logical step in their careers in research, academia, or
industry. Continued funding of this training grant will ensure that the community of vision scientists at OUHSC
will be able to provide a robust and motivating environment to prepare trainees for future careers in vision
research.

Public health relevance
PROJECT NARRATIVE The Vision Science Training Program in Oklahoma will recruit and train students pursuing a PhD or MD degree (pre-doctoral trainees) or individuals who already have the PhD or MD degree (postdoctoral trainees) to perform clinical and basic science research in vision science. An outstanding group of investigators spanning several departments and two institutions has interfaced to create a collaborative and highly competitive, yet nurturing environment for our trainees to excel. Training in research laboratories of well-funded, highly productive, and nationally and internationally recognized scientists, along with a strong program in vision science course work, retreats/workshops, clinical experiences, and national/international meetings will provide training critical for future vision scientists in the United States.